Decoding the mechanical interactions between tissue layers sculpting organ shape

PROJECT SUMMARY/ABSTRACT
Organ shape is vital for proper function. Malformations in the looping and folding of the heart, for
instance, represent the leading cause of birth defect mortality in humans. Visceral organs rely on the
coordinated activity of multiple laminar tissue layers to fold and coil into targeted shapes. While the community
has learned much about the genetic signals governing cell fates during development, less is understood about
the mechanical stresses and tissue dynamics that translate gene expression into the shapes of organs. This
proposal aims to link hox gene expression to physical forces driving 3D multilayer organ shape change using
the D. melanogaster midgut as a model system.
The midgut begins as a tube of two concentric tissue layers that undergoes a sequence of constrictions
to fold into chambers. Hox genes — conserved master regulators of patterning during development — have
long been known to govern the ﬁnal shape of this organ, but the mechanical stresses and tissue dynamics
translating hox expression into organ shape have remained elusive. We recently found that organ constrictions
proceed through a mechanical program mediated by calcium pulses in the outer layer, under the control of hox
genes. Advances in light-sheet microscopy now enable live visualization of the whole organ at sub-cellular
resolution during development. Integrating these imaging methods with physics approaches provides the ability
to follow cell dynamics across tissue layers throughout morphogenesis and quantitatively relate genetic
patterning in the tissue to the tissue mechanics and dynamic cellular behaviors driving 3D shape change.
The proposed work aims to ﬁrst (1) decode the relationship between the hox gene expression pattern to
the downstream pattern of calcium pulses in the midgut. (2) Secondly, a physical model will relate calcium
pulses to tissue-scale mechanical stress, using spatiotemporal maps of calcium activity to constrain an in silico
model of the morphing tissue. Together, these aims will reveal how genetic patterning controls a mechanical
process to sculpt complex shapes in a bilayer organ. (3) Finally, this proposal will address how the midgut
model visceral organ coils into a chiral tube later during development. Recent discoveries of `cell intrinsic'
chirality, in which cytoskeletal machinery breaks left-right symmetry, have proven to provide a major role in
determining organ-scale chirality. The mechanical process by which cell chirality translates into 3D organ-scale
shape change, however, remains largely unknown. By combining the in toto imaging toolkit and molecular
biology approaches mastered during the K99 phase with my expertise in chiral mechanics from my PhD, this
aim will link cellular chirality to the dynamics of organ-scale coiling.
Together, these research aims and the training in biology, microscopy, and modeling during the K99
phase will ensure I am equipped to begin an independent research lab revealing the physical mechanisms
harnessed by biology to sculpt complex shapes of visceral organs.

Public health relevance
PROJECT NARRATIVE During development, genetic patterning instructs tissues to form complex shapes that are crucial for proper function. Using whole-organ live imaging and approaches from physics, this study will analyze how gene expression patterns and cell-scale chirality govern tissue-scale mechanical forces to sculpt visceral organs.